Molecular mechanisms mediating the soft tissue attachment to teeth

Summary of Parent R01
Maintaining the junc-onal epithelium (JE) is essen-al to preserve cementum, periodontal ligament (PDL), and alveolar bone.
New insights into JE barrier func-ons came with our discovery of a Wntresponsive stem cell niche in the JE. In this proposal,
our goal is to characterize the cellular players, niche signals, and regulatory mechanisms that control and maintain the JE
stem cell niche in health, and aGer damage or disease. AIM 1 experiments will test whether Wnt/β-catenin signaling is
necessary for JE maintenance. Pathway inhibi-on will be achieved in Axin2LacZ/+ mice using adenovirus expressing the soluble
Wnt inhibitor Dkk1; controls will receive adenovirus encoding the Fc por-on of immunoglobulin G. Quan-ta-ve analyses
will assess endogenous Wnt/βcatenin signaling via Xgal staining; JE hemidesmosomal gene and protein distribu-on via
quan-ta-ve immunohistochemistry (qIHC); JE and GE cell cycle kine-cs by EdU/BrdU labeling; and inﬂammatory cell
inﬁltra-on in connec-ve -ssues underlying the JE and GE by FACS. Second, whether Wnt/β-catenin signaling is necessary for
JE regenera-on will be determined by subjec-ng Wnt lineage tracer e.g., Axin2CreERT2/+;R26RmTmG/+ mice to par-al
gingivectomy followed by Ad-Dkk1/Ad-Fc delivery. Lineage-tracing and quan-ta-ve analyses will establish a rela-onship
between Wntresponsive cell progeny, cell cycle kine-cs, hemidesmosomal gene and protein distribu-on, and regenera-on
of JE barrier func-ons. AIM 2 experiments will evaluate the ability of a stabilized formula-on of WNT protein to regenerate
a func-onal JE . In one injury-repair model the JE will be surgically excised; in a second model, JE breakdown will be triggered
via a ligature-induced periodon--s; both will be carried out in Axin2LacZ/+ and Axin2CreERT2/+;R26RmTmG/+ mice. Delivery of the
WNT therapeu-c will be followed to assess re-establishment of JE barrier func-ons. AIM 3 experiments will characterize
Wnt-responsive JE stem cells and their progeny. Wnt-responsive stem cell pools from adjacent gingival epithelium (GE) will
serve as control. Axin2CreERT2/+;R26RmTmG/+ mice will be exposed to tamoxifen, followed by harvest of JE and GE -ssues at
deﬁned -mepoints. GFP+ cells will be sorted by ﬂow cytometry. Gene expression proﬁling of GFP+ cells will focus stem cell
and diﬀeren-a-on markers. Fluorescent in situ hybridiza-on will conﬁrm gene expression pacerns using RNA probe libraries
corresponding to stem cell markers, components of Wnt/β-catenin, Notch, and Bone Morphogene-c Protein (BMP)
pathways. Collec-vely, this proposal has the poten-al to iden-fy an innova-ve therapeu-c strategy for rebuilding a damaged
JE and thus open new avenues for the restora-on of the soG -ssue acachment following periodontal diseases.
Proposed Supplement
The JE acts as an essen-al barrier against bacterial infec-on, which is crucial in preven-ng periodontal diseases. In this
proposed diversity supplement, we will look to elucidate the role of Wnt/β-catenin signaling in maintaining the barrier and
acachment func-ons of the JE. Extended Aim 2 experiments will use a transgenic mouse model with a defect in Wnt
signaling, e.g., OCN-Cre;Wlsﬂ/ﬂ, to evaluate if the JE and Wntresponsive stem cell niche become disrupted. Alveolar bone
morphology will be assessed by µCT tomography; inﬂammatory cell response and JE hemidesmosomal proteins via qIHC;
and bone remodeling ac-vity by TRAP/ALP assays. This proposal has the poten-al to advance Wnt therapeu-c treatments
for periodontal diseases, which can then be made more uniformly accessible to disadvantaged communi-es.

Public health relevance
Project Narrative The junctional epithelium (JE) serves as the first line of defense against periodontal diseases, and its barrier functions are maintained by a stem cell niche. Here, we will identify and characterize the roles of Wnt/β-catenin signaling in maintaining the stem cell pool during JE homeostasis and injury repair and test a biochemical approach for re-establishing JE barrier functions after damage. The proposed R01 diversity supplement will take a genetic approach by using a Wnt- deficient mouse model to extend our understanding of Wnt/β-catenin signaling in upkeeping the JE’s barrier and attachment properties.